ESTABLISHING OUTCOMES FOR THE BALTIMORE LONGITUDINAL STUDY OF AGING COHORT. THE

To perform home-based visits in the BLSA participants who, for different reasons, cannot come to the study clinic in Baltimore for a traditional follow-up evaluation. Initially, these visits will include 481 BLSA participants who are currently inactive but never officially dropped out of the study. It is expected that an average of 150 participants will become eligible for the home visit program for each of the 5 years of follow-up, except for the first year when it is expected to have 125 eligible participants. Home visits shall be performed following the schedule specified for regular BLSA visits to the study clinic (every 4 years for participants less than 60 years old, every two years for 60-79 and annually for 80 and older). The main objectives are to: perform follow-up evaluations of BLSA participants who cannot come to Baltimore for a traditional assessment in the study dinic;create outcome measures that maximize the scientific use of the extensive data previously collected in these participants;increase the value of the study by reducing the biasing effect of "informative censoring";expand the collection of biological samples in participants who have developed substantial comorbidity and disability;obtain informed consent from participants for the use of biological samples that they previously donated to the study to address new research questions.